Microbiomes regulate neutrophil responses in sepsis

Microbiomes regulate neutrophil responses in sepsis.
Sepsis is defined as a systemic inflammatory response to infection that causes vital organ dysfunction. Although
sepsis is one of the most common causes of hospital death, patient responses to this disease are highly
heterogeneous, making it difficult to identify the critical pathophysiologic processes that lead to sepsis mortality.
The normal human microbiota, which plays a fundamental role in the induction and training of the host immune
system, is known for its highly heterogeneous composition across different individuals in homeostasis. Growing
evidence suggests that the diverse homeostatic microbiome factors are responsible for the heterogeneous host
responses to infection and inflammation. The main question to be addressed in this proposal is whether
microbiomes in healthy blood differentially prime the immune system, thus differentially predisposing patients to
sepsis. Here, we present unpublished preliminary evidence from our laboratory suggesting that (1) in healthy
human blood, neutrophils are differentially “trained” (or “primed”) by the microbiome, leading to altered responses
to inflammatory stimulation; (2) unlike in human, neutrophils isolated from mice kept in specific-pathogen-free
(SPF) facilities (“clean” mice), do not show the microbiome-mediated priming; (3) however, mice that carry wild
mouse microbiomes ("dirty" mice) successfully recapitulate the microbiome-mediated training of neutrophils; and
(4) furthermore, adoptive transfer of neutrophils from "dirty" mice significantly improves septic survivals in “clean”
mice. Migration of neutrophils to sites of tissue infection is vital for pathogen clearance and, thus, host survival.
However, neutrophils become hyperactive during sepsis, and they mediate much of the morbidity and mortality
associated with the disease. Our overarching hypothesis in this proposal is that the microbiome-mediated
priming of neutrophils during homeostasis influences the exaggerated inflammatory response during sepsis. Aim
1 investigate the mechanism underlying the microbiome-mediated immune priming of human neutrophils.
will
Aim 2 will determine the effects of the microbiome-mediated priming on sepsis mortality using “dirty” mouse
models. This proposal addresses mechanisms regarding how the dysregulated host response threatens patient
survival and offers a molecular target for dampening the destructive arms of the hyperinflammatory response
while promoting disease resolution and tissue recovery.

Public health relevance
Although sepsis is one of the most common causes of hospital death, patient responses to this disease are highly heterogeneous making it difficult to identify the critical pathophysiologic processes that lead to sepsis mortality. This study will determine the underlying mechanisms that lead to heterogeneous patient responses to sepsis. Understanding how to control tissue damage through manipulation of neutrophil function has potential applications in many acute/chronic inflammatory settings including sepsis.